Characterizing novel Beta-lactamases from metagenomic samples: insights into the evolution of antimicrobial resistance from the environment towards human-associated pathogens

PROJECT SUMMARY
β-Lactamases are the most widespread resistance mechanism to β-lactam antibiotics. Of particular
concern are a group of β-lactamases known as carbapenemases, named for their ability to destroy
our newest β-lactam antibiotics, the carbapenems. The rise of carbapenem resistance is a recent
global trend that has resulted in pan-national fear. An interesting approach to understand
carbapenem resistance and how it evolves is through quantitative analysis of non-pathogenic
microorganisms found in the environment. Analysis of these microorganisms offers the intriguing
possibility of predicting how antibiotic resistance may evolve and provides clinicians with an
“early warning” system for the advent of novel resistance mechanisms in pathogenic bacteria.
Previous research has shown that the soil is an excellent repository for many β-lactamases,
especially carbapenemases. The main part of the project will be the study of a collection of
metagenome-origin β-lactamases isolated from Alaskan soil, named LRA (for “β-lactam resistance
from Alaska”). This metagenomic approach will be expanded and applied to the analysis of soil
samples from Antarctica to identify β-lactamase-mediated resistance in different isolated regions.
Identified environmental β-lactamases will be characterized using a multi-pronged approach
involving phenotypic, molecular, biochemical and structural techniques. Specifically, results from
this comprehensive analysis will allow us to assess the evolutionary routes of β-lactamases found
among clinical pathogens that plague human health today, and to evaluate novel niches of
potentially unexplored genes that could be recruited by these pathogens.

Public health relevance
PROJECT NARRATIVE Antimicrobial resistance is one of the most pressing public health crises of the 21st century. Carbapenem-hydrolyzing -lactamases are a particularly concerning resistance mechanism to our last line antibiotics, the carbapenems. The proposed research on antimicrobial resistance in environmental microorganisms will inform physicians of potential novel -lactamases that may threaten human health before their emergence in the clinic, which is entirely in line with the mission of the NIH and NIAID.